Understanding How Adolescent Bullying Experiences Affect Traumatic Stress,Sexual Health and STI Risk among Men Who Have Sex with Men (MSM)

Project Summary
This research project focuses on the interplay of bullying, psychological health and STIs among
Men Who Have Sex with Men (MSM). Due to pervasive stigma and homophobia, this vulnerable
population is often exposed to bullying during adolescence. However, research on MSM sexual
health has not focused on this exposure, making is a significant gap in the literature. Defined by
the CDC as a public health problem, bullying can take many forms, from intermittent teasing to
physical violence. The current generation of MSM may also have been exposed to social media-
based cyber-bullying. In order to adequately describe individuals’ experiences with bullying, this
study will use survey methods in combination with purposive qualitative interviews. We will
examine the association of exposure to bullying during adolescence with current psychological
status, in particular symptoms associated with posttraumatic stress. We expect that MSM who
experience bullying may subsequently evidence symptoms consistent with PTSD including
intrusive memories of the bullying, uncontrollable anger, overwhelming guilt or shame, and
difficulty maintaining close relationships. They may also experience depression, low self-esteem,
self-destructive behavior, anxiety and suicidal ideation, which may present as part of PTSD or be
comorbid with PTSD. In general, we expect that MSM subject to more extreme bullying will
experience greater PTSD symptoms as well as poorer sexual health, including higher HIV risks.
Individual differences in social support during and after adolescence may attenuate this
relationship. Nonetheless, we hypothesize that traumatic symptoms related to bullying will have
ramifications for men’s sexual health and risk behavior. If these hypothesized relationships are
supported, it would point to the need for a bullying-specific intervention targeting the long-term
deleterious consequences of MSM bullying.

Public health relevance
Relevance to Public Health The proposed project addresses a known psychological stressor, adolescent bullying among men-who-has sex with men (MSM), a well-known vulnerable population. The consequences of severe and/or frequent bullying may lead to Post-Traumatic Stress if the victim is not sufficiently resilient. Moreover, MSM often experience other forms of sexual minority stress and stigma that, coupled with bullying victimization, can lead to long-term deleterious effects, including higher STI/HIV risks for young adult MSM.